Developmental Research Project Program

Project Summary/Abstract – DRP Program The Developmental Research Project Program is at the heart of the activities of SC INBRE as the mechanism by which Target Faculty are selected and supported to continue expand the network and build biomedical research infrastructure in the state. The thematic areas of the DRP are in line with those of SC INBRE as a whole, with a strong focus on Regenerative Medicine (specifically, at the CRUs) Cell and Molecular Biology, and Neuroscience. In addition, projects in biomedical disciplines that make extensive use of Bioinformatics methods and technologies will be considered in the DRP Program. Independent investigators at the Assistant (most commonly) or Associate Professor level at participating SC INBRE network or outreach institutions, who work in or are interested in developing research projects focusing on any of the areas of interest of SC INBRE, are eligible to participate. Applicants from PUIs will be tenure-track or tenured faculty. Applicants from CRUs may be tenure-track, tenured or research faculty. Faculty eligible for DRP Program funding may not be PIs of substantial NIH research project grants (R01, R21, R15, or COBRE projects). It is expected that most DRP applicants will be junior faculty at the beginning of their career. However, individuals at more advanced stages of their career who desire to re-tool, enter a new area of research, and re-gain competitiveness for independent NIH funding will also be considered, if they meet the other criteria listed above. Each award will be of $50,000 for one year, renewable for up to three years. Six awards will be made to CRU faculty and eight to PUI faculty. There will be a single process for the external and internal review of DRP proposals, however PUI faculty will not compete directly with CRU faculty as the. The Administrative Core staff will organize and manage all aspects of the DRP program and a subcommittee of SC INBRE's Steering Committee, including mentors with the appropriate range of expertise, will manage the review. The final selection of proposals for funding will rest with the EAC. DRP Program support will be accompanied by considerable SC INBRE and institutional resources that will expand the impact of the funds and provide Target Faculty with ample opportunities for success, including intensive mentoring, career development, training and access to instrumentation resources. Former and current SC INBRE target faculty have enjoyed considerable success and many of them are now in a position to serve as mentors to junior faculty in the network and/or as reviewers in the DRP Program. Target faculty will “graduate” from DRP support when they earn an NIH Research Project Grant, but will continue to enjoy facilitated access to the SC INBRE resources and facilities, and to train SC INBRE students.

Public health relevance
Project Narrative – DRP Program The Developmental Research Project Program selects and supports the career development of SC INBRE Target Faculty to continue expand the network and build biomedical research infrastructure in the state, and provide hands-on research training to students. Target Faculty will have ample opportunities for success, including intensive mentoring, career development, training and access to instrumentation resources. Former SC INBRE target faculty have enjoyed considerable success and many of them are now in a position to serve as mentors to junior faculty in the network and/or as reviewers in the DRP Program. DRP Program Target faculty will “graduate” from DRP support when they earn an NIH Research Project Grant, but will continue to enjoy facilitated access to the SC INBRE resources and facilities, and to train SC INBRE students. The career development of biomedical faculty is one of the most important means by which SC INBRE accomplishes its goals of bringing research training opportunities within reach of all students, whether at CRUs or PUIs, and independently on their ethnic, racial or economic background.